Function of a putative iron transporter in the Plasmodium apicoplast

PROJECT SUMMARY/ABSTRACT
Human malaria caused by Plasmodium falciparum parasites remains a devastating infectious disease marked
by increasing treatment failures with frontline artemisinin combination therapies. Plasmodium parasites have
evolved specialized metabolic strategies that enable them to infect and grow within red blood cells. Identifying
these adaptations will give insight into Plasmodium evolution and identify new parasite-specific therapeutic
targets. Parasites require nutritional iron to support critical metabolic pathways that include DNA synthesis and
repair, ribosome assembly, mitochondrial electron transport chain function, and isoprenoid precursor synthesis
in the apicoplast organelle. Although it has been known for decades that iron chelators effectively block parasite
growth inside red blood cells, the pathways and mechanisms used by parasites to obtain iron for intracellular
metabolism remain sparsely defined. Identification of iron transporters has been especially challenging given low
sequence similarity between many parasite proteins and well-studied proteins from other organisms, including
yeast and mammals. Our long-term goal is to understand essential functions of the apicoplast whose inhibition
causes immediate rather than delayed parasite death. Our overall objective in this proposal is to elucidate an
essential mechanism for iron uptake by the apicoplast, which is critical for parasite synthesis of isoprenoid
precursors and depends on Fe-S cluster biogenesis within this organelle. Basic mechanisms of iron uptake into
the apicoplast are currently unknown. In an exciting preliminary advance, we have used an innovative
affinity screen to identify a highly divergent parasite protein (Pf3D7_1248300) that is targeted to the
apicoplast and shows high structural homology to pentameric metal transporters in bacteria, to which
the endosymbiotic apicoplast is evolutionarily related. In proposed studies, we will test our central
hypothesis that this protein is essential for parasite viability and required for iron-dependent metabolism in the
apicoplast. We will test this hypothesis in two aims. First, we will use CRISPR/Cas9 to tag the gene encoding
this putative transporter to encode an epitope tag and a conditional regulation system that enables ligand-
dependent protein expression. We will use these tagged parasites to test and understand the sub-organellar
localization and essentiality of this protein for parasite viability and apicoplast biogenesis. In a second aim, we
will test if knockdown of this protein selectively impairs iron-dependent metabolism inside the apicoplast. These
studies will unravel a new molecular paradigm for iron mobilization into the apicoplast organelle and unveil a
potential new therapeutic target, especially as preliminary results suggest that small molecules can selectively
target this protein. These studies will also involve the rigorous training of a talented female PhD student from
an underrepresented Native American background and mentorship of a summer undergraduate student through
the Utah Genomics Summer Research for Minorities or Native American Research Internship programs.

Public health relevance
PROJECT NARRATIVE Human malaria caused by Plasmodium falciparum parasites remains a devastating infectious disease marked by increasing treatment failures with frontline artemisinin combination therapies. These parasites require nutritional iron for survival, but their cellular mechanisms to acquire and distribute iron remain largely undefined. The proposed studies will test the essentiality and function of a putative iron transporter targeted to a key parasite organelle, thus elucidating a critical metal acquisition mechanism and defining a potential new therapeutic target.